Core A: Administration

Core A: Summary
Core A, the Administrative Core of the Center for Serological Testing to Improve Outcomes from
Pandemic COVID-19 (STOP-COVID) will ensure management and coordination of all STOP-COVID research,
as well as appropriate communications and integration both across our Center and with the other components
of the broader SeroNet. Core A is focused on Management, Communication, Networking, and Evaluation
activities through the following aims: 1) Provide research oversight, establishing Center management and
communication structures; 2) Ensure integration of our Center with the SeroNet via meetings, networking, and
coordination of opportunities for Trans-Network Collaborations and Data Sharing, and 3) Oversee Center
Program Evaluation and Reporting, monitoring Center progress. Core A will also ensure the data collected
across the Center to STOP-COVID Center conform with the agreed practices and principles of the SeroNet
Standard Operating Procedures (SOPs), Common Data Elements (CDEs), and data sharing plan, as approved
by the SeroNet Steering Committee. The members of Core A will work together to foster an environment
of transdisciplinary research excellence to ensure achievement of all aims of the STOP-COVID Center
and its embedded Research Projects and Cores.